FLUVASTATIN ON CORONARY ATHEROSCLEROSIS IN PATIENTS WITH LDL-CHOLESTEROL

To compare the effectiveness and safety of fluvastatin versus placebo, in conjunction with diet, in slowing the progression of coronary atherosclerosis in patients with mild and moderate elevation of ldl-cholesterol.